Bioinformatics, Statistical and Methodological Shared Resources Core

ABSTRACT – BIOINFORMATICS, STATISTICAL AND METHODOLOGICAL CORE
The primary goal of the Bioinformatics, Statistical, and Methodological (BSM) Core at the Florida-California
Cancer Research, Education & Engagement (CaRE2) Health Equity Center is to provide the data management,
data cleaning, data storage, and data release to public databases for all information generated by our Center. In
addition, it will provide bioinformatics, statistical and methodological support for all the cancer research projects
proposed, as well as future projects that will build upon them and disseminate to all CaRE2 Center members and
the scientific community at large in a timely fashion. We will reach these goals through three aims: First, we will
provide bioinformatics, statistical and methodological support. This first aim established the job scheduling and
interfaces to meet the needs of all CaRE2 Health Equity Center investigators. We will support bioinformatics and
statistical issues across the projects and cores. Bioinformatics support will include in-depth quality control and
assessment of all high-throughput sequencing data from multiple platforms and facilitate access to publicly
available datasets. Statistical and methodological support will consist of all aspects, from collecting to state-of-
the-art data analysis and interpretation and abstract, manuscript, and grant preparation. The second aim will be
enhancing and maintaining a federated data repository resource that enables the interaction of CaRE2 members.
This second aim ensures that all data are of high quality and disseminated to all CaRE2 Center members and
the scientific community promptly. In the third aim, we will provide bioinformatics, statistical and methodological
support, and educational opportunities to the CaRE2 Center. This third aim focuses on developing online
educational materials that BSMC's members and guest experts will present through the core events, such as
seminar series and interactive lectures among all CaRE2 Center members.